Dual Modality X-ray Luminescence CT for in vivo Cancer Imaging

Dual Modality CT/X-ray Luminescence CT for in vivo Cancer Imaging
ABSTRACT
A combined X-ray CT and molecular imaging system, referred to as “CT/X-ray luminescence CT (XLCT)”, is
proposed. The system uses X-ray as a single source to image anatomy and molecular features from
simultaneous detection of luminescence signals of X-ray activatable molecular probes. In this technique, the
spatial information is obtained by exciting the sample using spatially selective X-ray patterns while optical
detectors placed around the sample measure luminescence photons diffusing out. Regardless of where these
photons are detected, it is known that they are created somewhere on the path of the coded X-ray beams. This
fundamental principle constitutes a new paradigm for imaging deep-seated light-emitting probes, with little
background from tissue auto-fluorescence. Another significant advantage of XLCT is that X-ray excitation is
amplified by orders of magnitude because of the extremely high quantum yield (2-4 orders of magnitude greater
than 100%) of the radioluminescent materials. Toward establishing XLCT for various biomedical applications
and eventually for clinical applications, we have assembled a multidisciplinary team consisting of leading
investigators with expertise in CT imaging, molecular imaging, biochemistry, medical physics, computational
science, and medicine, and established research themes that unify the common interests and expertise of these
investigators. If successful, the hybrid CT/XLCT will overcome many of the limitations of CT and optical
imaging methods and enable us to visualize biological processes in the anatomical CT image context with
unprecedented sensitivity, specificity and spatial resolution. The novel dual modality imaging strategy will
therefore significantly advance the field of cancer imaging and provide a valuable imaging tool for biological
and clinical studies.

Public health relevance
Dual Modality CT/X-ray Luminescence CT for in vivo Cancer Imaging NARRATIVE The goal of this project is to develop a novel dual modality imaging system of CT and X-ray luminescence CT (XLCT) for simultaneous imaging of anatomy and biological features in living subjects. XLCT uses X-ray- activatable molecular probes to obtain biological information while simultaneously providing anatomical CT images. The development promises to impact fundamentally on biomedical imaging research and will lay foundation for human imaging applications in the future.